Investigator Development Core

Modified Abstract Section: FIU-RCMI Investigator Development Core (IDC) ABSTRACT
Expanding the cadre of well-trained researchers committed to addressing the complex underlying drivers of disease within the United States is an urgent priority. In particular, more researchers are needed to improve our capacity to cultivate new insights into the root causes and to identify innovative, feasible, and pragmatic solutions. The purpose of the Investigator Development Core (IDC) is to support the overall goals of FIU-RCMI by fostering and promoting rigorous health disparities research with mentorship, training, and research opportunities for early-stage investigators (ESIs). For the proposed renewal application, the IDC will build on and improve its established pilot project and mentoring program for promising ESIs to help enhance their career development. The IDC will provide ESIs a three-phase support system, comprised of Pre-Pilot, Pilot Project, and Post-Pilot phases with the accompanying 3 Specific Aims: Aim 1. Annually recruit and establish a cohort of promising ESIs (Pre-Pilot Phase) by: a) providing health research and grant writing training; b) soliciting R03-like health-focused pilot applications; c) providing a rigorous NIH-like peer-review process, in which all applicants receive constructive feedback; d) providing ongoing grant writing support for unfunded applicants; and e) evaluating the application and peer-review process for transparency. Aim 2. Provide multifaceted support to each cohort of ESIs during the implementation of their 1-2 year pilot project (Pilot Phase) by: a) assisting each cohort in navigating university research procedures and implementation challenges; b) ensuring all projects comply with applicable Federal research policies, laws, and regulations; c) monitoring the progress of all projects; d) supporting each ESI in pilot research outputs of peer-reviewed publications, presentations, and grant proposals; and e) providing Monthly Cohort Meetings with a professional development curriculum. Aim 3. Provide a mentoring program for ESIs (Pre-Pilot, Pilot Project and Post-Pilot Phases) by: a) assisting ESIs with identifying potential mentors and providing them with training about establishing and maintaining mentoring relationships; b) providing mentors with mentorship and related training; and c) monitoring mentoring team effectiveness. The mentoring program will be open to all ESIs interested in health disparities research. By the end of the five-year period, the program will result in a minimum of 100 ESIs – from a wide variety of academic and research backgrounds – who will have benefited from participating in the trainings, mentorship, and support provided by the IDC. Between 17-20 of these 100 ESIs will receive pilot funding and have successfully completed their pilot projects. All ESIs will receive grant writing and research training and mentoring to help bolster and prepare the next cadre of well-trained, committed researchers to combat and address disease in the United States.

Public health relevance
The Research Center in Minority Institutions at Miami Dade’s Florida International University (FIU-RCMI) has provided extensive research support and training for early-stage investigators (ESIs), partnered with South Florida communities to conduct health research, and capitalized on our community connections for supplementary research. This competitive renewal proposal builds upon our achievements, refines our approaches to early stage investigator mentoring and community research partnership, and broadens our scope. Our scientific focus areas will include basic biomedical research, behavioral research and population science, and clinical/health services research, with two research projects.